Targeted Pathway Activation for PosturalInstability and Gait Disorder in Parkinson'sDisease

Project Summary and Abstract
Parkinson's disease (PD) symptoms of postural instability and gait disorder (PIGD) cause profound
disability and are inadequately treated by current therapies. Deep brain stimulation (DBS) of the
subthalamic nucleus (STN) and Globus Pallidus (GP) is effective for PIGD, but not nearly as much as
for other PD symptoms e.g. bradykinesia and rigidity. Standard DBS optimization relies on assessing
changes in symptoms each time stimulation changes, a very time consuming process. PIGD changes
slowly in response to changes in stimulation. Hence, DBS is normally optimized to quicker-
responding symptoms, which may be why DBS works better for symptoms other than PIGD. The goal
of DBS optimization is to affect neural target structures which best ameliorate symptoms. Different
target structures may ameliorate different symptoms. While bradykinesia and rigidity are thought to
respond to stimulation of the subthalamopallidal projection, PIGD is thought to involve other
structures, especially pedunculopontine nucleus (PPN). PPN afferents and efferents, passing through
or near STN & GP may therefore be more effective stimulation targets for PIGD.
New directional DBS electrodes, coupled with high field strength MRI imaging and patient-specific
computational models, now enable more selective targeting of these pathways. We hypothesize that
targeting the ascending PPN efferent pathway will increase the effectiveness of DBS on PIGD,
whereas targeting the descending pallidofugal pathway, by inhibiting PPN, will decrease its
effectiveness for PIGD.
We will compare effects on gait, postural instability, bradykinesia, and rigidity, of DBS
targeting pedunculopallidal and pallidopeduncular pathways, directly, as well as subthalamopallidal
pathway directly, pallidosubthalamic pathway directly, and pallidopeduncular pathway
indirectly (by targeting inhibitory afferents to GP pars interna GPi). Preoperative 7 Tesla
structural and diffusion-weighted MRI scans and postoperative high-resolution CT scans will
determine electrode location and orientation, relative to nuclei and fiber tracts. Patient-specific
models from these imaging datasets will estimate percent activation of each fiber tract, and a
novel particle swarm optimization will design stimulation settings maximizing the difference in
activation between pathways being compared. Aims 1 (STN) & 2 (GP) compare settings in a single-
session, within-subjects experimental design. Aim 3 compares settings with much longer wash- in/
out intervals, and will also collect data between laboratory testing sessions using measures of
functional status and quality of life. This project will comprehensively investigate how DBS can
be tailored on a patient-specific basis to treat disabling symptoms of PIGD.

Public health relevance
Project Narrative Parkinson's disease (PD) symptoms of postural instability and gait disorder (PIGD) cause profound disability and are inadequately treated by current therapies. This project uses new brain-imaging and computer-modeling techniques to comprehensively investigate how targeting deep brain stimulation (DBS) at specific path- ways on a patient-specific basis can effectively treat the disabling symptoms of PIGD.